Elucidating the role of PATZ1 in MYCN-amplified neuroblastoma

Project Summary
Neuroblastoma is the most common extra-cranial cancer that affects children, accounting for
approximately 15% of childhood cancer deaths. Children are typically diagnosed with neuroblastoma
under the age of 5 years old with an average of between 1-2 years of age. MYCN-amplified
neuroblastoma comprises approximately 20-25% of all neuroblastoma cases, has a 5-year survival rate
of approximately 50%, and it is associated with therapy resistance and lower survival rates. Despite
improvements in the five-year survival rate for high-risk neuroblastoma, current therapies are
aggressive and negatively impact the quality of life for patients with neuroblastoma. Therefore, there is
an urgent need to develop novel therapies that improve both the mortality and morbidity rates of patients
with neuroblastoma.
Using the Broad Institute’s Dependency Map (DepMap), I identified PATZ1 (POZ/BTB and AT Hook
Containing Zinc Finger 1) as a selective and potentially druggable dependency in neuroblastoma.
Currently, the role of PATZ1 in cancer has varying reports as both a possible tumor suppressor and
oncogene, and further investigation is needed to elucidate the role of PATZ1 in tumorigenesis and tumor
cell maintenance. My preliminary data has confirmed that neuroblastoma cells have decreased viability
after PATZ1 knockout using CRISPR Cas9 technology. In addition, preliminary CUT&RUN and ChIP-
seq analysis suggests that PATZ1 binds coordinately with members of the core regulatory circuitry
(CRC), including MYCN, to regions of open chromatin marked by enhancers. The CRC is responsible
for regulating the cell fate of neuroblastoma, leading me to hypothesize that PATZ1 plays a critical role
in maintaining the oncogenic cell state of neuroblastoma.
In this proposal, Aim 1 will assess PATZ1 as a potential therapeutic target in neuroblastoma by
rigorously testing the effect of PATZ1 knockout and degradation both in vitro and in vivo. To elucidate
the mechanism of action of PATZ1 dependency in neuroblastoma, Aim 2 will evaluate the transcriptional
and epigenetic consequences of PATZ1 knockout and degradation in neuroblastoma cell lines. This
work will validate a new druggable dependency in neuroblastoma and expand our understanding of
epigenetic factors driving the oncogenic cell state of neuroblastoma.

Public health relevance
Project Narrative Neuroblastoma is the most common extra-cranial solid tumor affecting children, and the overall 5-year survival for patients with high-risk neuroblastoma, which is characterized by MYCN-amplification, remains at about 50%. Current therapies are aggressive with lifelong consequences, prompting the urgent need for improved therapies for treating neuroblastoma. This project aims to validate PATZ1 as a dependency in neuroblastoma, uncover the role of PATZ1 in disease pathogenicity, and biochemically characterize the epigenetic and transcriptional consequences of PATZ1 loss in neuroblastoma, which could lead to a new therapeutic approach for treating neuroblastoma.